Immune response to COVID-19 vaccination in individuals with immune disorders

Patient enrollment is underway and appropriate in each category. We will continue to collect both remote and in person data from subjects and to observe the response to vaccination. We will also be able to see the effects of booster vaccinations. Efforts to be sure that we have balance of subject populations are underway and will be effective.The ability to use home blood testing kits has been critical insofar as it has allowed us to collect blood in subjects' homes and to ship it to the NIH for plasma elution and antibody assay.